Randomized clinical trial of a telemedicine-mHealth symptom cluster intervention for advanced cancer patients: Increasing access in underserved rural communities

Abstract
People with advanced cancer experience a greater frequency and severity of physical and psychological
symptoms, ranking sleep difficulties, worry-anxiety, depression, and fatigue as four of the most common and
distressing symptoms. These symptoms form a symptom cluster, contribute to functional impairment and
poorer quality of life, and are undertreated, especially in rural communities. There is strong evidence for
biobehavioral interventions to improve these symptoms. However, cognitive-behavioral (CBT) and acceptance
and commitment therapies (ACT) are often too time and energy intensive (e.g., 12-20 sessions) and not
tailored for people with advanced cancer. Preliminary Results. In response to specific needs of people with
advanced cancer, we completed a pilot randomized, controlled trial of a brief, integrated CBT-ACT intervention
utilizing the most effective components of these treatments. Finding Our Center Under Stress (FOCUS) is a
four-module mHealth intervention that teaches patients how to control symptoms, when possible, while
continuing to live meaningfully despite these symptoms. FOCUS participants demonstrated statistically and
clinically significant improvements on insomnia severity (d=-0.98), worry (d=-0.86), depression (d=-0.77),
fatigue interference (d=-0.59), self-report and physiologic sleep efficiency (effect size d=0.92), sleep latency
(d=-0.66), and psychological distress (d =-0.78). The proposed project, guided by the biobehavioral theoretical
model, will build on the success of our pilot trial and complete a larger effectiveness trial of FOCUS compared
to a telemedicine-mHealth information control on this symptom cluster; evaluate dose-response, particularly
among rural patients; and explore biobehavioral mediators of symptom changes. Our primary goal for this
study is to improve this symptom cluster, functional status despite symptoms, and quality of life for people with
advanced cancer from underserved rural communities. Innovative features include our population (50% rural
and Appalachian), symptom cluster focus, telemedicine-mHealth delivery, tailoring for people with advanced
cancer, and use of a biobehavioral approach. Aim 1. Evaluate the effectiveness of FOCUS on a symptom
cluster (sleep-anxiety-depression-fatigue), Aim 2. Determine the impact of FOCUS dose on symptom severity
and interference and examine usage by patient geographic location and gender. Exploratory Aim 3: Examine
biobehavioral mediators of treatment effects. Design and Method: This is a prospective, triple blinded (patient,
research assistant, statistician), single-site, randomized trial of FOCUS vs information control. We will recruit
120 participants with advanced lung, prostate, breast cancer, myeloma, and melanoma. The trial will take
place at The Ohio State University James Comprehensive Cancer Center. All participants will complete
assessments at baseline, 6 and 12 weeks, and 6 and 12 months. We hypothesize that FOCUS participants
who use the app more frequently will demonstrate improvements on the symptom cluster longitudinally
compared to the control group via psychological, inflammatory, and endocrine mediators.

Public health relevance
Project Narrative IMPACT: This project expands the reach of evidence-based cancer symptom cluster self-management to rural, underserved communities through a clinical trial. We leverage the power of technology to improve access via telemedicine and mHealth. An effective, accessible, brief alternative to medication-based symptom management is essential given the limited availability of palliative and psychosocial care for advanced cancer patients, especially in rural communities, and the impact of these symptoms on functional status, quality of life, and treatment tolerance.